Alabama Dept of Agriculture AFRPS Maintenance & Mutual Reliance FY25

Funding Opportunity – PAR-25-003: Animal Food Regulatory Program Standards
Implementation Development and Maintenance, with Mutual Reliance Initiatives
Applicant: State of Alabama, Department of Agriculture and Industries,
Agricultural Compliance Section
Abstract – Project Overall
As with other state animal feed programs, ours is not a revenue generating program. To that
end it makes it difficult to have the needed funds appropriated to our program for improvements
in equipment and technology. The Agricultural Compliance section is currently in the final year
of the funding opportunity RFA-FD-24-035: Development and Maintenance of the Animal Feed
Regulatory Program Standards.
This funding opportunity is allowing us to access funds to maintain the Animal Feed Regulatory
Program Standards. It also enables us to make significant improvements to our program with
the purchase of new equipment and technologies not only for the regulatory program but also
for our testing laboratory. This opportunity is affording us the capability to update and, in some
cases, replace equipment to improve the effectiveness of our sample collection, storing,
transporting and analytical abilities. Accordingly, we will be able to maintain programmatic
improvements for years to come that will help ensure the safety and integrity of the U.S. animal
feed supply.
Our program will utilize specific members of our staff to develop and execute a plan to establish
and become fully implemented in all standards and to maintain the standards. The specific
members of our staff include the division director, program manager, field inspector supervisor,
testing laboratory director, testing laboratory quality control director and an office assistant.
Concurrently our testing laboratory will be taking all necessary steps fulfilling Standard 10 and
becoming ISO/IED 17025:2005 certified. Standard Operating Procedures (SOP) will be
developed and maintained in every area where they would be appropriate to address all aspects
of the program.
This program has been and will continue to be a participant in the Animal Feed Contract. We
have been able participate in some training opportunities and to attend the AFRP’s Face to
Face Meetings. Also, the funding enables more involvement by more of the staff in AAFCO.
Currently our staff consists of a division director, eleven Agricultural Compliance staffers, which
includes eight inspectors, a program manager and one office staff, five testing laboratory staff
and two registration staff.
We will be assigning certain task to the following: By utilizing the funds offered here we will be
able to continue maintaining the standards outlined in the funding opportunity. The unit manager
of the Ag Compliance section will be the primary personnel in the maintenance of the AFRPS
and coordinating the goals of the Mutual Reliance Track. Individuals from the Ag compliance
section will attend the AAFCO annual and midyear meetings and the Annual AFRPS F2F
meeting.

Public health relevance
Funding Opportunity – PAR-25-003: Animal Food Regulatory Program Standards Implementation Development and Maintenance, with Mutual Reliance Initiatives Applicant: State of Alabama, Department of Agriculture and Industries, Agricultural Compliance Section Year AFRPS Development Phase AFRPS Maintenance Phase Mutual Reliance Track Total Amount Requested 1 $ $ 150,000.00 $150,000.00 $300,000.00 2 $ $ 150,000.00 $150,000.00 $300,000.00 3 $ $ 150,000.00 $150,000.00 $300,000.00 Narrative – Overall Project CONCLUSION By utilizing specific members of our staff in a concentrated effort we will be able to maintain implementation of all the standards to assist in creating a national, fully integrated food safety system. Meanwhile, our laboratory staff will maintain ISO/IED 17025:2005 Certification. The upgrades and replacement of current equipment, the procurement of new technologies and equipment and the introduction of standard operating procedures will put our program in a stronger position of maintaining the Animal Feed Regulatory Standards and performing non-contract inspections of firms.